Boosting Bioethics & Bioprinting

PROJECT SUMMARY
Three-dimensional (3D) bioprinting technologies (including extrusion-, droplet-, and laser-based 3D bioprinting)
have been accelerating at a rapid pace and could be revolutionary for precision medicine. The development
and refinement of these bioprinting techniques offer potential for the precise manufacturing cells, tissues, and
organs to be used in clinical care (such as organ transplantations) and for use in important biomedical
research (such as in-vitro tissue models for drug screening and disease modeling). Despite the remarkable
progress and improvements in 3D bioprinting technologies, they are not without challenges (including
vascularization challenges that impede biofabrication of complex structures, such as bone tissue and
bronchopulmonary segments). It is essential for the safe, effective, and equitable design, development, and
ultimate use of 3D bioprinting technologies that the ethical, legal, and social issues (ELSI) are addressed
proactively and concurrently with the scientific challenges. For this reason, bioethics research capacity building
initiatives are urgently needed. To begin to address this need, the proposed project launches a new
interdisciplinary collaboration—involving engineering, bioethics, anthropological, and legal expertise—to create
high-quality, profoundly integrative educational resources and opportunities specifically for current and future
scientists and engineers in the field of 3D bioprinting. In this one-year supplemental project, we will inspire
intellectual curiosity and expand awareness in ELSI among regenerative medicine faculty and students by
hosting a new webinar series on bioethics and bioprinting (Aim 1); creating novel educational modules and
resources for an integrated and adaptable approach to bioethics and bioprinting training (Aim 2); and offer
unique educational opportunities while evaluating the educational modules and resources (Aim 3). By
leveraging the unique strengths of Penn State University (including, notably, the Huck Institutes of the Life
Sciences; the Rock Ethics Institute; and the Law, Policy and Engineering Initiative) and by strategically bridging
an ongoing ELSI research project with an ongoing bioprinting research project, this proposed one-year
supplemental project is intended to produce tools that support instructors in the larger bioethics community and
to encourage other scholars to transcend siloed research practices and dismantle structural obstacles that
hinder much needed multidisciplinary, interdisciplinary, and transdisciplinary collaborations.

Public health relevance
PROJECT NARRATIVE Three-dimensional (3D) bioprinting technologies have been accelerating at a rapid pace and could be revolutionary for precision medicine, enabling the precise manufacturing of cells, tissues, and organs for both clinical care and biomedical research. In order for these 3D bioprinting technologies to be ethically and equitably designed, developed, and used, researchers must hone their skills to address not only the scientific challenges (such as vascularization challenges that impede biofabrication of complex structures) but also the ethical, legal, and social issues (ELSI) arising with them. This project will boost bioethics and bioprinting research capacity with high quality educational opportunities and resources.